Understand the mechanisms through which genetics, biology, and social determinants affect cancer risk and outcomes in diverse populations, to motivate interventions to reduce cancer inequities

Overall Abstract
Prostate, breast and pancreatic cancers all have a disproportionately higher rate of aggressive
tumor grade and early onset in Black patients, with recent spikes of high incidence in west African
nations compared to other African regions. The genetic background correlations implicate
predispositions. Members of our SAMBAI team of investigators have pioneered genomics in
cancer disparities research and over the past two decades we have uncovered compelling
evidence of distinct immunological mechanisms associated with genetic ancestry. Our SAMBAI
team members have developed methods to quantify environmental exposures and interrogate
lived experiences of marginalized populations including epigenetic responses racism. Aims We
will partner with scientists across the US, Africa and the UK to build an unprecedented resource,
the SAMBAI Biobank and Data Repository for Cancer Equity Research. We will generate a
comprehensive, accurate and relevant measurement of social, environmental, genetic and
immunological factors to complete an integrated set of analyses to define the causal vs. modifier
relationships of disparate outcomes in diverse underserved populations. We will establish a
sustainable framework for team science approaches with under- represented partners and
establish best practices for coordinating cancer equity research on a global scale. Methods We
propose to utilize multiple methods across our different work packages. Social Determinants
includes self- reporting surveys and database abstractions. Exposomes utilize mass spectrometry
of plasma. Genomics will utilize three sequencing methods on germline and tumor tissue,
including long-read, short/deep and ultra-low pass whole genome sequencing. Lastly,
immunological profiles will be measured with spatial transcriptomics and circulating multiplex
immunoassays. These data require novel computational frameworks, including cloud- based
virtualization and use of machine learning technologies to identify novel associations across the
strata of social to spatial data elements and across our diverse geographic and ancestral SAMBAI
cohorts. Utility and Impact We will improve research capacity in under-resourced environments
for large scale cancer research and equitable access to data with equitable feasibility to improve
treatment and outcomes. We will define interactions of environmental exposures, social
determinants, and genetic ancestry that determine immunological landscapes of primary tumors
and/or circulating immunological profiles in patients of African descent. Our project will contribute
a data repository with 100K features/patient, for 40,000 patients. The impact to this population
includes a novel trial design, in collaboration with our patient advocacy partners, to ensure that
the specific genomic and immunological features we uncover become part of targeted precision
oncology theragnostic options